A novel method to identify regulators of biological aging  based on high-throughput sequencing of epigenetic clocks.

Project Summary
Epigenetic clocks based on DNA cytosine methylation (DNAme) are currently the most robust biomarkers
of aging in mammals. They can accurately estimate the age of diverse biosamples and are responsive to
interventions–such as caloric restriction or rapamycin treatment—that are thought to slow aging. Despite their
increasing ubiquity in the field, the biology underlying epigenetic clocks is poorly understood. Likewise, their
potential as a readout to test pharmaceutical interventions and discover new aging-associated genes is yet
unrealized. One of the main limitations to using DNAme clocks at scale is the cost of current methods. Commonly
used technologies to assay epigenetic age, such as methylation chip and RRBS, measure hundreds of
thousands of CpGs and cost hundreds of dollars per sample. An economical, targeted approach that can
measure virtually any epigenetic clock is badly needed to enable larger experiments with epigenetic age as the
primary readout.
For the F99 phase of this proposal, I have developed a new method called Tagmentation-based Indexing
for Methylation SEquencing (TIME-Seq) that enables targeted DNAme clock sequencing of dozens to hundreds
of samples simultaneously. I have shown that TIME-Seq is capable of measuring diverse epigenetic clocks at a
range of scales and decreases costs 1-2 orders of magnitude. I plan to validate the method via comparison to
conventional methods and build novel epigenetic age predictors and biomarkers trained on age-related frailty
metrics.
In the K00 phase, I will investigate the biology driving epigenetic clocks using aging mouse muscle as a
model. I will take a multiomic approach, using TIME-Seq and established genomic methods, to test the
hypothesis that heritable loss of silencing at developmental loci, in part, drives ticking of the clocks.
This proposal will provide the aging field with a much-needed method for cost-effective and high-
throughput epigenetic clock assay, as well as novel biomarkers based on frailty, which can be used in academic
research and a clinical context. Ultimately, the method will help us understand how and why it is possible to build
DNAme clocks and what they tell us about epigenomic dysfunction during aging.

Public health relevance
Project Narrative Developing accurate, cost-effective, and scalable biomarkers of aging and age-related frailty could help in assessing longevity interventions in the lab or patient outcomes in the context of clinical trials of age-related disease. This proposal describes the development of a method for high-throughput assay of DNA methylation clocks, a robust class of age predictors, which will be used to make a novel type of biomarker based on age and mouse frailty scores. Additionally, this research will probe the mechanistic underpinnings of DNA methylation clocks and epigenomic change with age in mouse muscle using the novel method for clock analysis in combination with established genomic techniques.